Regulation of Cellular Phenotype Change in Thoracic Aortic Aneurysms

Thoracic aortic aneurysms (TAAs) develop as a consequence to abnormal remodeling of the aortic extracellular
matrix (ECM).10 This usually asymptomatic process results in a weakened aortic wall manifested as gross
dilatation that progresses to rupture. Current treatment includes blood pressure management until the risk of
rupture outweighs the risk of surgical or endovascular intervention; neither of which address the underlying
pathways which drive this devastating disease.11 TAA development is influenced by a series of interrelated
mechanisms such as the matrix metalloproteinases (MMPs) 12-15, and dysregulation of the production and
deposition of ECM proteins.16 Importantly, these mechanisms are mediated in part through changes in the
resident cellular constituents within the aortic wall.17, 18 Transforming growth factor-beta (TGF-β), a soluble
peptide growth factor capable of regulating the structure and composition of the aortic ECM, is a well described
mediator of fibroblast phenotype.19 Current data shows that the alterations in TGF-β signaling result in a type-I
TGF-β receptor switch, from a TGF-β-R1 dominant signal, to an ALK-1 dominant signal. TGF-β is sequestered
within the extracellular matrix, bound by latent TGF-β binding proteins (LTBPs).21, 22 These latent complexes are
proteolytic targets for key MMPs, such as membrane type-I MMP (MT1-MMP), which is induced during TAA
development.8, 23 Results demonstrated that TAA development was attenuated in MT1-MMP heterozygous
deficient mice, and neutralizing antibody treatment targeting either TGF-β ligands (TGF-β-NAb) or MT1-MMP
activity (MT1-MMP-InhAb) was sufficient to attenuate aortic dilatation; suggesting MT1-MMP as an important
mediator of TAA formation and progression. New data demonstrate an increase in the number of mature
macrophages (F4/80+) at 8- and 16- weeks post-TAA induction; suggesting that macrophage-derived MT1-MMP
may also contribute to TAA development. The present proposal will explore the time-dependent and cell-type
specific expression of MT1-MMP using an established and well-characterized mouse model of TAA induction,
and several unique transgenic mouse strains. The central hypothesis of this study is that MT1-MMP-dependent
activation of TGF-β signaling is both time-dependent and cell-specific, and it will be tested through three specific
aims: (1) Demonstrate that fibroblast-derived MT1-MMP is required for TGF-β release and fibroblast
transdifferentiation, early in TAA development. Using a validated Tamoxifen-inducible, fibroblast-specific Cre-
dependent (Col1A2-Cre-ERT2) knockout of floxed-MT1-MMP, MT1-MMP will be deleted in fibroblasts prior to
TAA induction (Early), or after 4-weeks of TAA development (Late); (2) Demonstrate that macrophage-derived
MT1-MMP is required for TGF-β release and the maintenance of fibroblast phenotype, late in TAA development.
Using a Tamoxifen-inducible, monocyte/macrophage-specific Cre-dependent (LysM-Cre-ERT2) knockout of
floxed-MT1-MMP, macrophage-derived MT1-MMP will be knockout. A) prior to TAA induction (Early), or B) after
4-weeks of TAA development (Late); and (3) Demonstrate the efficacy of the MT1-MMP activity-neutralizing
antibody as a potential therapeutic for the treatment of TAA disease. Mice will be treated with the antibody prior
to TAA induction (Early), or after 4-weeks of TAA development (Late). In each aim, the effects on aortic geometry
and structure, the activation of TGF-β signaling (pSmad-1/5/8), fibroblast phenotype/function, and the localization
of cell-type specific markers, and MT1-MMP, in the aortic wall will be recorded. Together this set of studies will
establish the time-dependent and cell-type-specific expression of MT1-MMP during TAA formation and
progression and define its mechanistic role in TAA development.

Public health relevance
Thoracic aortic aneurysms (TAAs), are a bulging of a segment of the main artery in the chest that delivers blood to the rest of the body. Patients with TAA, typically have no signs or symptoms of the disease. Once diagnosed, the patient enters a “watch and wait” program until the risk of aortic rupture outweighs the risk of undergoing open surgical repair. During this period, patients are typically treated with drugs that control their blood pressure under the assumption that it will help to prevent rupture. Because the Veteran population often has a higher than normal number of smokers and patients with high blood pressure, vascular disease, and diabetes, this places them at high risk for development of TAA. Currently, there are no non-surgical options to treat TAA disease. Therefore, the studies in this application are designed to help us understand the cell-specific mechanisms that cause TAA and may help developing better ways to identify, predict, and treat Veterans and the public at large.